University of Michigan (UM) HEAL Initiative National K12 Clinical Pain Career Development Program (UM-HCPDP)

PROJECT SUMMARY / ABSTRACT
The overall goal of the University of Michigan (UM) HEAL National K12 Clinical Pain Career Development
Program (UM-HCPDP) is to develop a national training program for early career clinician-scientists to grow the
next generation of clinical pain researchers. The UM-HCPDP is housed within the Chronic Pain and Fatigue
Research Center, a unit within the Department of Anesthesiology at the UM. The center possesses a
multidisciplinary and collegial culture with extensive didactic opportunities related to pain and research
methods, access to a diverse group of patient partners, and the expertise of faculty colleagues locally,
nationally, and internationally. The UM-HCPDP provides administrative functions for the National K12 program
such as selection of scholars, development and implementation of national guidelines for career development
and mentoring, as well as methods to evaluate career progress. Administrative functions also include
coordination of the scholars' experience which includes mentoring at the scholar's home institution, mentoring
by the UM-HCPDP K12 advisory committee (i.e., scientific and patient mentors), access to pain-specific and
general didactics, and linkages to the Coordinating Center for National Pain Scientists Program (CCNPS). The
UM-HCPDP also offers unique remote access to locally produced didactics in pain, general scientific methods
(e.g., ethics, rigor) and soft skills (e.g., leadership and job negotiation), as well as in-person access to summer
short courses (e.g., pain, epidemiology, data science). Three scholars per year will be selected in each of the 5
years and appointed to up to 3 years of training. Eligible applicants will be in their last year of residency,
fellowship, or post-doctoral training and/or within 1 year of starting a faculty position. All candidates must be
housed at an educational or professional organization in the U.S. that will commit to 75% protected
training/research time. Additionally all candidates must be committed to careers in clinical pain research with
the goal of professional independence at the conclusion of the training program. The UM-HCPDP seeks to
continually improve the Nation's ability to train clinician-scientists with a deep understanding of pain
mechanisms, non-opioid treatment options, scientific methodological rigor, leadership, patient-centric
perspectives, and compassion for those who are suffering.
Impact: The UM-HCPDP seeks to continually improve the Nation's ability to train clinicians and scientists with
a deep understanding of pain mechanisms, non-opioid treatment options, scientific methodological rigor,
patient-centric perspectives, and compassion for those who are suffering.

Public health relevance
PROJECT NARRATIVE The overall goal of the proposed University of Michigan (UM) HEAL National K12 Clinical Pain Career Development Program (UM-HCPDP) is to develop a national training program for early career clinician- scientists so as to grow the next generation of clinical pain research scholars. This national K12 program develops guidelines for career development and mentoring in clinical pain research, and coordinates training for scholars across institutions and mentorship teams, and with the Coordinating Center for National Pain Scientists Program (CCNPS). The UM-HCPDP seeks to train clinician-scientists with a deep understanding of pain mechanisms, non-opioid treatment options, scientific methodological rigor, leadership, patient-centric perspectives, and compassion for those who are suffering.